Neural and Molecular Mechanisms of Emotional Dysfunction after Sepsis

Project Summary/Abstract
This proposal describes a four-year career development plan designed to lead the PI to a career as an
independent clinician scientist studying the mechanisms of emotional vulnerability after severe medical illness.
More than one third of critical illness survivors suffer long term from depression, anxiety, or post-traumatic
stress disorder. Animal research on this topic is scarce, but is necessary in order to better understand the
mechanisms of vulnerability and to identify targets for intervention. The long-term goal of this research is to
identify the molecular mechanisms and neural circuitry behind emotional vulnerability after severe medical
illness, and to translate this knowledge into effective strategies for the prevention and treatment of psychiatric
disorders in critical illness survivors.
Preliminary studies using a murine sepsis model, cecal ligation and puncture (CLP), showed increased
anxiety-like behavior in CLP survivor mice, and in situ hybridization studies suggested a possible role for the
ventral hippocampus. In the first Specific Aim, the candidate will investigate the role of the ventral
hippocampus in anxiety-like behavior after CLP by examining the activity of ventral CA1 pyramidal cells after
CLP using in vivo calcium imaging, and determining the effect of optogenetic activation of the ventral
hippocampus on anxiety-like behavior.
Studies of patients after traumatic experiences including critical illness have suggested that elevated
circulating glucocorticoids during trauma may protect against post-traumatic stress symptoms in survivors. In
the second Specific Aim, the candidate will investigate whether glucocorticoid treatment during the illness
period can protect against negative emotional behavior in CLP survivors, and use RNA-seq to identify
candidate genes that could mediate the effects of CLP and glucocorticoids on ventral hippocampal function
and emotional behavior.
The applicant holds M.D. and Ph.D. degrees and has completed clinical specialty training in Internal
Medicine and Endocrinology. She has previous experience in behavioral endocrinology research using mouse
models. This application includes a career development plan designed to update her scientific skills in
techniques for investigating the neural circuits of behavior in awake, freely behaving animals, and in the design
and analysis of large-scale gene expression data. The training will include didactic training, conferences and
lab meetings, hands-on apprenticeship, and the communication of research findings through publications and
presentation at national meetings. The mentorship team includes members of multiple departments/divisions
and multiple institutions, in order to support this inherently interdisciplinary project. The mentors are able to
provide a research environment with adequate resources to complete the proposed project.

Public health relevance
Project Summary/Narrative More than one third of critical illness survivors suffer long term from depression, anxiety, or post-traumatic stress disorder. The goal of this research is to identify the brain areas and molecules that cause this increased vulnerability to mental health disorders in critical illness survivors, in order to develop effective strategies for prevention and treatment.